Brain-Behavior Mechanisms of Social Cognition in First-Episode Psychosis

PROJECT SUMMARY
Psychotic disorders are serious illnesses that lead to significant functional impairment, even during the early
course of illness (i.e., first-episode psychosis; FEP). Social cognition is a strong predictor of key functional
outcomes in psychosis (i.e., social and occupational functioning) and among social cognitive domains,
mentalizing – the ability to infer and reason about the mental states of other people – is most robustly impaired
and simultaneously most predictive of outcomes. However, existing interventions addressing social cognitive
dysfunction in psychosis are minimally effective in improving real-world outcomes. Further, though psychosis
studies have revealed abnormal function in brain areas comprising the mentalizing network (MN; e.g., medial
prefrontal cortex and temporoparietal junction), the vast majority of existing studies have utilized fMRI paradigms
that use non-human or non-interactive stimuli that may limit ecological validity and further fail to examine
associations between neural function and real-world outcomes. Collectively, social cognition is a critical factor in
psychosis that remains poorly understood. Thus, the proposed study will combine neural, behavioral, and real-
world functioning measures to delineate brain-behavior mechanisms of social cognition in FEP. The study will
enroll 45 FEP individuals and 45 matched non-clinical controls (NCC) and assess their neural (i.e., fMRI) and
behavioral (i.e., validated laboratory-based measures) social cognitive function as well as their real-world social
and occupational behavior. Data from this study will allow for an innovative investigation of whether MN
dysfunction is associated with social cognitive performance on validated behavioral tasks both across and within
FEP and NCC participants (Aim 1), and how these brain-behavior measures of social cognitive performance
relate to laboratory-based measures of social and occupational functioning (Aim 2). The current study will also
examine the extent to which MN function predicts real-world social and occupational functioning assessed via
ecological momentary assessment (Aim 3). This proposal concurrently provides an excellent opportunity to
receive mentor-directed, hands-on training in several key areas necessary to refine the candidate’s knowledge
and skill-sets. Though the candidate has extensive clinical research experience in FEP and has completed
foundational fMRI training, she proposes a training plan focused on three new domains: 1) advanced social-
cognitive neuroscience and fMRI task development, 2), linking of fMRI to behavioral constructs of social cognition
and functional outcome, and 3) translation of fMRI and behavioral constructs to psychosis. The proposed study
coupled with completion of the training plan will effectively launch the candidate toward her long-term goal of an
independent career in the translational neuroscience of social-cognitive dysfunction in early psychosis, and will
lay the foundation for future, high-impact R01 studies focused on refined identification and targeting of
biobehavioral factors influencing social and functional outcomes.

Public health relevance
PROJECT NARRATIVE Social cognitive impairments are highly prominent in psychotic disorders and have been linked to social and functional outcomes beyond the impact of other illness-related factors (i.e., psychiatric symptoms, nonsocial cognition), yet available treatments for social and social cognitive dysfunction are limited in their effectiveness. Despite recognition as an area of clinical relevance and unmet need, the brain-behavior mechanisms that give rise to social cognitive impairment in psychosis remain poorly characterized, thus limiting our attempts to target primary sources of observed dysfunction. The proposed study will examine the neural bases of mentalizing, a key social cognitive process in psychosis, and its association with clinical and real-world functioning in a transdiagnostic sample of young adults with first-episode psychosis.